Microscale Thermophoresis Instrument System for UCONN Biophysics Core Facility

Funds are requested for the purchase of a Microscale Thermophoresis (MST) instrument which will be used to investigate molecular interactions in vitro. It will be housed within the University of Connecticut’s Biophysics Core facility, a shared resource promoting research innovation through access to cutting-edge biophysical technology and expertise. It serves the main Storrs campus and the UConn Health Center, with a rapidly expanding user base currently consisting of over 30 laboratories as well as external industrial and academic users. MST offers a number of advantages over other methods for biophysical molecular interaction analysis, such as Isothermal titration calorimetry (ITC), and Surface Plasmon Resonance (SPR), and Analytical Ultracentrifugation. It does not require immobilization of the receptor, has low sample consumption, carries out rapid measurements, has a wide affinity range and wide size range for interactants (from small molecules to large macromolecular complexes, even ribosomes), and offers measurements in complex mixtures such as cell lysates. Most, if not all, cellular processes are mediated by complex networks of biochemical interactions. MST is a powerful technology that can be applied across a broad range of biomedical research fields. It is also a key technology to drive drug discovery. There are 12 NIH funded users with projects that require the MST instrument to make further progress characterizing molecular interactions relevant to human health and disease. Instrumentation available at the University of Connecticut to measure interactions is limited to ITC and SPR. Preliminary data obtained during our evaluation of MST demonstrate that the NanoTemper Monolith NT.115 instrument provides a substantial improvement compared to these technologies. This benefit was observed over a large number of diverse interactions. The Biophysics Core has become a major cornerstone of instrumentation support for NIH funded research at the University of Connecticut. There is a pressing need to add the MST instrument to upgrade the Facility’s biomolecular interaction capabilities and to support continued growth of this shared resource.

Public health relevance
Acquisition of a microscale thermophoresis (MST) instrument for the study of biomolecular interactions in vitro at the University of Connecticut Main Campus (UCONN Storrs) and the Health Center Campus (UCH Farmington) will advance the research aims of 16 externally funded researchers at University of Connecticut. These investigators pursue a range of basic science and translational research programs with a shared focus on gaining a better understanding of protein-protein, protein-nucleic acid, protein-substrate and protein-small molecule interactions. A significant portion of the research is focused on small-molecule drug discovery.